Shared Resource Management

ABSTRACT: SHARED RESOURCE MANAGEMENT (SRM)
Shared Resource Management (SRM) is the authoritative unit responsible for six CCSG-supported Shared
Resources (SRs) providing state-of-the-art support services and technology to SKCC members throughout the
Sidney Kimmel Cancer Center (SKCC) consortium. SRM is the administrative governing body, providing access
to specialized technologies, services, and expertise that enhance scientific development and productivity of
SKCC SRs (also known as Core Facilities) ensuring that cost-effective, state-of-the art services are made
available to members regardless of location across the consortium. These services facilitate and support
breakthrough discoveries and innovations across SKCC’s four Research Programs. SRM is led by the Associate
Director (AD) for Shared Resources (SRs), Matthias Schnell, PhD, with administrative support provided by
dedicated staff in the Office of Cancer Research Administration (OCRA). Under Schnell’s leadership, SKCC re-
configured SRs’ scientific and administrative operations to best serve the cancer research community. An
extensive review of all SRs was conducted in 2021, with guidance from the Shared Resources Oversight
Committee (SROC), Senior Leadership Committee (SLC), Research Executive Cabinet (REC) and an external
consulting firm that guided the planning and evaluation process. The team launched a comprehensive survey to
all cancer center members, assessed policies and procedures, reviewed management operations, and examined
fiscal records of all SRs present in the previous Cancer Center Support Grant (CCSG) application. Upon
completion of an extensive process, the SROC presented recommendations to SLC and REC, and received final
approval from the SKCC Director. SKCC proposes the following SRs to be included in this application:
Biostatistics, Bioinformatics, & Research Informatics (BBRISR), BioImaging (BISR), Cancer Genomics (CGSR),
Flow Cytometry and Human Immune Monitoring (FCHIMSR), Integrated Structural Biology (ISBSR), and
Translational Pathology (TPSR). SRM reviews finances, staffing, and business planning with the Vice
President/AD Administration (Huesser) and the Assistant Director for Shared Resources (Marrone) monthly.
Informed by the scientific recommendations made by SLC and REC along with financial insight from OCRA,
Schnell recommends actions to the Center Director who maintains authority over all SR management decisions.
SRM supports the SKCC mission with the following Specific Aims: 1) Foster and facilitate the use of leading-
edge scientific services, technologies, consultation, and expertise to promote research that aligns with the
programmatic themes of the strategic plan and the catchment area; 2) Provide operational oversight, cost
effectiveness, accessibility, business planning, customer satisfaction, and feedback that expand scientific
excellence; and 3) Expand educational, training and outreach opportunities for the SKCC research community
to strengthen productivity and collaborative efforts.